Personalized risk assessment in Neurofibromatosis Type 1

Project Summary/Abstract
Neurofibromatosis (NF) encompasses a set of complex genetic disorders that affect almost every organ system
and increase risk for the development of benign and malignant central and peripheral nervous system tumors. Of
the three types of NF, Neurofibromatosis Type 1 (NF1) is the most prevalent occurring in approximately 1 in
every 3,000 births without predilection for race, sex, or ethnicity. While NF1 is inherited in a fully penetrant
autosomal dominant manner, there is wide inter-individual variability with respect to clinical features and their
impact on patient morbidity. Clinical heterogeneity is a pervasive challenge for clinicians and families, as
the management of children and adults with NF1 remains largely reactive, without reliable biomarkers
or predictive models for early risk stratification and/or prognostic assessment at the time of diagnosis.
Traditional approaches, which focus on identifying a single clinical or biological marker that can be measured
and used to assess disease risk or trajectory in NF1, have achieved limited success and have hindered progress
in the development of precision medicine for NF1-affected individuals. In response to these challenges, and with
the opportunity to improve the care of individuals with NF1, we aim to verify and validate an alternative and
generalizable approach for developing artificial intelligence (AI)-based clinical decision support tools for NF1
sub-phenotypes, implemented and evaluated in a comparative manner across two clinical sites.
Our proposed project will first generate a multi-scale data set using a text-mining based clinical phenotyping
algorithm to integrate and harmonize data from multiple sources such as clinical databases, structured
electronic health records, and unstructured clinical notes. Secondly, we will develop AI-based pipelines
capable of generating predictive models and tools to identify disease risk for three critical NF1 sub-
phenotypes (OPGs, scoliosis, and ADHD). We will then evaluate the models for quantitative accuracy and
clinical actionability at the point of care with the help of NF1 clinicians. Finally, we will validate these methods
and models across multiple sites, so that we can better understand the challenges to generalizing and
transporting such predictive models based across different healthcare systems, environments, and populations.
We anticipate that the use of artificial intelligence techniques in order to study NF1-specific sub-phenotypes at
two different sites will yield novel and potentially clinically-actionable and generalizable insights concerning the
precision diagnosis and care of individuals with NF1, with broader applicability across a spectrum of similarly
complex disease-states.

Public health relevance
Project Narrative This study will utilize a set of artificial intelligence methods to evaluate large quantities of data derived from individuals with Neurofibromatosis Type 1 (NF1), a complex genetic disease with the potential to affect every organ system, in order to develop clinical decision support tools that can predict disease risk at the individual patient level. The knowledge gained from such studies will enable physicians and patients (or their family members) to better manage the treatment of NF1 over a lifespan, thus increasing the timeliness and safety of care, as well as the quality of life of those individuals and their care providers. Further, given the similarity of NF1 to many other diseases that involve a complex interaction of genes, clinical features, and other measurable characteristics, the methods we develop should be applicable to a broad variety of conditions beyond NF1 and improve our ability to deliver precision medicine, with ensuing benefits in terms of the costs, quality, and outcomes of healthcare.